Impact of Novel Rehabilitative Approaches FOR Dysphagia in Patients with Alzheimer's Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
This career development proposal is designed to provide Nicole Rogus-Pulia, PhD, CCC-SLP, a Speech-
Language Pathologist and an expert in dysphagia (swallowing dysfunction) at the University of Wisconsin-
Madison School of Medicine and Public Health with the training required for success as an independent, clinician-
scientist researching interventions to improve the care of dysphagia in patients with Alzheimer’s Disease and
Related Dementias (ADRD). Dysphagia frequently develops in patients with ADRD and leads to serious health
consequences, including increased caregiver burden, malnutrition, pneumonia, decreased quality of life, and
mortality. Common treatments for dysphagia in patients with ADRD employ compensatory approaches that alter
bolus flow to avoid aspiration (entrance of food or liquid into the airway). These approaches do not result in
sustained improvements in swallowing physiology and often negatively affect quality of life. There are currently
no effective treatments for dysphagia in patients with ADRD that can be practically applied or have lasting effects
on the physiology of the swallow. The goal of Dr. Rogus-Pulia’s proposed research is to develop effective
dysphagia rehabilitative interventions for patients with ADRD at risk for adverse health consequences.
Progressive-resistance lingual strengthening and saliva substitute are two interventions that have been shown
in preliminary studies to positively influence swallowing function in older adults. This proposal will consist of a
small, prospective randomized clinical trial to determine the impact of two novel interventions on swallowing-
related outcomes in patients with mild-moderate ADRD and identify subgroups of patients most likely to benefit
from these interventions. Patient-caregiver dyads will be randomized to lingual strengthening, saliva substitute
use, a combination of the two, or only usual care. Saliva and swallowing-related outcomes will be collected at
baseline and following the 8 week intervention period. As a third aim, qualitative interviews with African American
patients with ADRD and their caregivers will be analyzed to explore cultural adaptations to the study protocol or
intervention materials to improve future trial participation among this underrepresented group. These data will
support a large, multi-site R01 funded study to determine effectiveness of dysphagia interventions for prevention
of adverse health outcomes in a diverse cohort of patients with ADRD. As a junior faculty member at an institution
with extensive infrastructure to support early stage investigators, Dr. Rogus-Pulia is in an ideal environment to
complete the proposed research and pursue advanced training. Her career development plan includes both
coursework and mentored training in the areas of 1) clinical trials design and analysis, 2) ADRD clinical care and
caregiving, 3) advanced statistical techniques, 4) qualitative methods, and 5) cultural competence. To ensure
success, she has identified committed, expert mentors in these disciplines and secured protected time for this
work. This award addresses a significant clinical dilemma and serious gap in ADRD research while affording the
education and mentorship critical for Dr. Rogus-Pulia to lead an independent dysphagia research program.

Public health relevance
PROJECT NARRATIVE Patients with Alzheimer’s Disease and Related Dementias (ADRD) frequently suffer from dysphagia, or swallowing dysfunction, that can lead to serious health consequences, including impaired oral intake, malnutrition, decreased quality of life, increased caregiver burden, and aspiration pneumonia. The proposed work will test the impact of two interventions, tongue strengthening and saliva substitute use, on swallowing- related outcomes in patients with mild-moderate ADRD. Additionally, interviews with African American ADRD patients and their caregivers will be conducted to identify important cultural adaptations for enhanced participation in future trials.